System Dynamics of PD-1 Signaling in T Cells

PROJECT SUMMARY/ABSTRACT
Adaptive immune responses are governed by T cell receptor (TCR) signaling, which determines the fates and
activities of T cells (helper, effector, etc.). The TCR and its signaling partners integrate antigen-recognition
signals and second signals, which carry information about the context in which antigen presentation is
occurring. Second signals can be either stimulatory or inhibitory: stimulatory signals are essential for T cell
activation, whereas inhibitory signals (also called checkpoints) are responsible for T cell exhaustion and
antigen tolerance. Stimulatory second signals are generated by the innate arm of the immune system when, for
example, signaling by Toll-like receptors induces expression of the B7-family ligands B7-1 (CD80) and B7-2
(CD86) on antigen-presenting cells. Expression of B7-1/B7-2 indicates that antigen presentation is occurring
within the context of an ongoing innate immune response. B7-1 and B7-2 are recognized by CD28, a TCR
coreceptor that potently enhances TCR-generated T-cell activation signals. Inhibitory second signals arise
during the course of chronic stimulation of TCR signaling. They are important for limiting the collateral damage
caused by an immune response and avoidance of autoimmunity, but they can also be deleterious. For
example, tumor cells commonly express the B7-family ligands B7-H1 (PD-L1/CD274) and B7-DC (PD-
L2/CD273), which are recognized by PD-1, a TCR coreceptor that inhibits TCR-generated T-cell activation
signals. B7-H1/B7-DC expression conveys immune privilege to tumor cells. For these and other reasons, it is
imperative that we improve our basic understanding of checkpoint signaling. Here, we propose to characterize
the dynamics of PD-1-regulated tyrosine phosphorylation in Jurkat E6-1, HuT 78, and TALL-104 cells,
CRISPR-engineered cells derived from these parental cell lines, and primary human CD8+ cells. We will apply
quantitative mass spectrometry (MS) to obtain an unbiased, nearly comprehensive picture of phosphotyrosine
(pTyr) site abundances with and without PD-1/CD28 coreceptor signaling in populations of T cells over time
and across conditions. Concurrently, using fluorescence microscopy and engineered SH2 domain affinity
reagents, we will characterize single-molecule patterns of multisite phosphorylation for TCR, CD28, and PD-1.
We will also measure membrane-recruitment lifetimes for individual cytosolic signaling partners of these
receptors. The resulting data will be used to drive the formulation and parameterization of a detailed
mechanistic model for TCR signaling accounting for the effects of CD28 and PD-1 coactivation. Although PD-1
is viewed as a platform for recruitment of phosphatases that counteract activation signals from kinases, we will
evaluate specific hypotheses about how PD-1 could potentially generate positive signals for T-cell activation.
These hypotheses are motivated by the fact that the best characterized signaling partners of PD-1 are protein
tyrosine phosphatases, SHP1 and SHP2, which are known to promote cell activation in other contexts by, for
example, mediating the dephosphorylation of inhibitory pTyr sites. Model predictions will be tested.

Public health relevance
PROJECT NARRATIVE We will characterize PD-1 immune checkpoint signaling dynamics in T cells by using quantitative mass spectrometry-based phosphoproteomics, single-molecule fluorescence microscopy, bioinformatics, and mechanistic mathematical modeling. A better basic understanding of PD-1 signaling, which plays an important role in avoidance of autoimmunity and escape of cancer cells and pathogens from immune surveillance, has the potential to motivate evaluation of new therapeutic strategies for diverse diseases.